Pacific Northwest Center for Cryo-EM

Cryo-electron microscopy (cryo-EM) has transformed the biomedical field by enabling researchers to examine molecular biology components with unparalleled detail. In 2018, the National Institutes of Health (NIH) established a national network of cryo-EM centers, including the Pacific Northwest Center for Cryo-EM (PNCC), to meet the growing demand for access and training in this groundbreaking technology. Over the past five years, PNCC, along with partner centers in New York (NCCAT) and Stanford (S2C2), have become an indispensable resource for the structural biology community. The field of cryo-EM continues to advance at a tremendous pace, driven by technological breakthroughs in instrument design, computational algorithms, and specimen preparation methods. It is expected that developments in machine learning and artificial intelligence will also play a significant role in enhancing cryo-EM workflows and automating various aspects of the process. These advancements in the field of cryo-EM are enabling researchers to study increasingly complex biological systems, capture low-abundance targets, analyze time-resolved reaction pathways, and obtain precise details of biomolecular interactions. The continued growth in cryo-EM promises to facilitate discoveries in basic sciences, biomedical research, and the pharmaceutical industry for years to come. With the rapid technological progress comes an increasing demand for access to high-end cryo-EM instrumentation and training opportunities. It is therefore essential to ensure access to resources and training to investigators entering the field. Additionally, support is needed for established researchers in applying cutting-edge technologies to challenging high-value structural biology targets. The PNCC is committed to meeting the evolving needs of the cryo-EM community through effective and innovative approaches in service, training, and outreach. PNCC benefits from the partnership between Oregon Health & Science University (OHSU) and Pacific Northwest National Laboratories (PNNL), both of which provide unique expertise, resources, and infrastructure. The highly experienced operational team at PNCC is adept at managing center resources, adapting to evolving developments, and providing high-quality training in cryo-EM methods to both new and experienced cryo-EM practitioners. Working with its partners, PNCC will position the center at the forefront of the field, develop and implement new and efficient workflows and training programs, and engage with the community to ensure that the benefits of all advances are widely disseminated. To expand the reach of cryo-EM, PNCC will continue to pursue innovative, sustainable approaches to overcome barriers of access and utilization. The future holds exciting opportunities and challenges for PNCC as it continues to pursue its missions and contribute to the advancement of cryo-EM.

Public health relevance
Oregon Health & Science University (OHSU) and the Pacific Northwest National Laboratory (PNNL) will continue to operate a user-focused, state-of-the-art national center for cryo-electron microscopy, designated as the Pacific Northwest Center for Cryo-EM (PNCC). PNCC will support researchers from a broad range of biomedical disciplines in elucidating the structures of biological molecules and macromolecular complexes using high-resolution cryo-EM. The center will also provide education in the theory and practice of this enabling technology to expand access and promote its effective application across the biomedical research community.